Core B: Computational Genomics Core

Core B: Computational Genomics Core. Core Director: Raul Rabadan
The Computational Genomics Core will provide a centralized structure to collect, analyzed and
integrate data from all three projects. Simultaneous genomic, transcriptomic and proteomic
mapping of bone marrow tissue will provide a unique opportunity to map cell types, their states
and pathway specific expression patterns in a spatially resolved manner. In addition to current
already implemented computational pipelines, the Core will develop new techniques that will be
applied across projects, implement methods for data integration and provide quantitative training
and computational support. The Core leaders (Drs. Rabadan and Wang) and their groups have
proven expertise in developing and successfully implementing mathematical and statistical
computational methods for large scale genomic analysis and data integration. Their work will be
integrated with that of Drs. Gaublomme and Greenblatt who have developed and are further
developing spatial mapping technologies to profile in situ cell states in the BM niche and delineate
their intercellular communication patterns. Datasets will be mined to chart the rewiring of both cell
states in the bone marrow niche and their aberrant signaling during AML transformation.
Additionally, Core B will include a partnership between quantitative and bench scientists that will
develop new techniques in addition to refining and implementing locally existing techniques
across all 3 projects. More specifically, the Core will: i) provide analysis of genomic data including
single cell mutational profiling through implementation of public pipelines, as well as through
internally developed approaches; ii) characterize cancer AML evolution from mutational profiling
data using Genotyping of Transcriptomes (GoT) and the MissionBio Platform, including
refinement of clonal trajectory inference; iii) analyze single cell transcriptomic and chromatin data
and integrate approaches across projects; iv) implement and improve computational approaches
for systematic analysis of spatially resolved multi-omic data; v) integrate data across technologies
and projects, including the characterization of genetic, epigenetic and transcriptomic states.

Public health relevance
Core B: NARRATIVE The Computational Genomics Core will provide a centralized structure to collect, analyze and integrate data from all three projects. Simultaneous genomic, transcriptomic and proteomic mapping of bone marrow (BM) tissue will provide a unique opportunity to visualize the numerous cell types, their states and pathway specific expression patterns in a spatially resolved manner. The generated datasets will be mined to chart the rewiring of both cell states in the BM niche and their aberrant signaling during AML transformation. The Core will apply methods for processing and analysis of single-cell RNA sequencing data, inference and visualization of AML clonal evolution, reconstruction of transcriptional regulatory networks and analysis of transcriptional targets, and integration of data across technologies.